Evaluation of Cardiovascular Health Outcomes among Survivors 2 (ECHOS-2)

ABSTRACT
Greater than 85% of children newly diagnosed with cancer will be cured and become long-term survivors.
Compared to the general population, survivors are at increased risk for cardiomyopathy (i.e., heart muscle injury)
and progression to symptomatic and potentially fatal heart failure, largely due to anthracycline chemotherapy
and / or chest-directed radiation exposure. Approximately two-thirds of survivors received one or both, placing
most at risk for cardiomyopathy. Practice guidelines exist to facilitate early screening for and detection of
asymptomatic cardiomyopathy in an effort to reduce progressive or symptomatic disease. However, adherence
rates are poor, with fewer than 40% actually completing screening. Most survivors are unaware of their risks and
followed by primary care providers who are poorly informed about recommended follow-up screening. In our
previous randomized controlled trial Evaluation of Cardiovascular Health Outcomes among Survivors (ECHOS-
1; R01 NR011322; MPI: Hudson/Cox), we demonstrated that advanced practice nurse (APN) led motivational
interviewing doubled screening adherence rates (52.2% vs. 22.3%) compared to mailed educational materials
alone. While effective, the APN-led intervention was not scalable to larger survivor groups. To address this, we
developed and tested an eHealth version of ECHOS-1, i.e., the Healthy Hearts pilot study. We now propose the
ECHOS-2 study, which will test the efficacy of the Healthy Hearts, eHealth-delivered intervention on
cardiomyopathy surveillance adherence. Among adult survivors participating in the Childhood Cancer Survivor
Study (CCSS; U24 CA055727; PI: Armstrong), 2,037 were treated with anthracyclines or chest-directed radiation
and have not received cardiomyopathy screening in the preceding 5-years, thus are eligible to participate. Of
these, 350 will be randomly assigned to the (1) control or (2) eHealth intervention arms. All will receive the
standard of care (educational handouts and a survivorship care plan). In addition to these same materials, the
eHealth arm will receive the Healthy Hearts, eHealth-delivered intervention, including avatar-led interaction and
video vignettes derived using motivational interviewing techniques. Vignettes have been designed to address
common barriers previously identified in ECHOS-1 and the Healthy Hearts pilot study, and are tailored to
individual patient’s baseline ECHOS-2 survey responses. The primary outcome is cardiac screening adherence,
defined as completion of an echocardiogram, confirmed by medical record review. A broad-based health
behavior model adapted to childhood cancer survivors will guide the intervention. Secondary aims will evaluate
whether behavioral constructs mediate the effect of the intervention on screening adherence, and whether or not
elements of the intervention are acceptable to survivors. Knowledge derived from this research will provide the
background for future evaluations of the impact of health screening on improving quality of care and reducing
cancer-related morbidity in childhood cancer survivors.

Public health relevance
PROJECT NARRATIVE Adult survivors of childhood cancer are at risk for late-onset cardiomyopathy due to prior anthracycline and cardiac radiation exposure, yet despite the establishment of screening guidelines to facilitate early identification and intervention, most survivors and their primary care providers are unaware of these recommendations and are not adhering to screening echocardiograms. This proposal is designed to test the efficacy of an eHealth- delivered, motivational interviewing-based intervention tailored towards individual baseline behaviors and perceived barriers to improve survivor adherence to cardiomyopathy screening. We expect the intervention to increase cardiomyopathy screening adherence, potentially reducing cardiovascular morbidity and mortality in this at-risk population.